Global Center on Climate Change and Water Energy Food Health Systems

Climate change has multiple pathways to directly and indirectly impact human health. There is a strong
connection between global warming and agricultural crops production through low precipitation, high
temperatures, and drought. The lower crops production impacts quality and quantity of foods and their
availability to low income communities. Our parent grant is leading the field of research in climate change and
health through the Global Center for Climate Change and Water Energy Food and Health Systems
(GC3WEFH) in rural Jordan. We are bringing together a large and diverse group of scientists to develop
solutions and potential policies and interventions to help vulnerable populations cope with climate change
health impacts. In this Administrative Supplement we will complement the existing focus of the parent grant on
water quality and quantity with new data and focus on dietary quality and quantity. We established a robust
team of scientists and community engagement of residents in the municipality of Alkhaldyia in Northern Jordan
to address water access through an intervention of water desalination. This supplement will extend this effort to
understand diet quality and food security within this same community and its relation to water and
noncommunicable diseases in the context of climate change. We will recruit up to 100 homes from the target
population and 1) measure nutrient adequacy, sources, and dietary quality of consumed food as risk factors for
noncommunicable diseases; 2) determine if farming communities have adequate access to food and the level
of food insecurity among these impoverished communities; and 3) include the collected dietary data into the
WEFH modeling and tradeoff analysis that is being developed by the parent GC3WEFH project. We will
expand our team to include expertise in clinical nutrition and train graduate students to apply methods of food
assessment at the population level to be included in the parent grant’s Water-Energy-Food-Health nexus. The
supplement will provide insight into the complex climate-agriculture-food-nutrition-health context and in relation
to climate change impacts of low quality and quantity of drinking water. We have data collected on water use
and access through the parent grant which this diet data will complement to help us understand the Water-
Energy-Food-Heath Nexus within rural Jordan.

Public health relevance
Narrative Climate Change is relevant to food production, water access, energy use, and health. Diet is related to crop production and food security, which is impacted by weather patterns in terms of precipitation, temperature, and drought. Less developed countries and their disadvantaged communities are most vulnerable yet we do not have a good understanding of these risks. To understand the connection of diet access and quality in low income rural communities to these environmental factors, our study assesses dietary behavior and health outcomes in rural Jordan that can help us develop policies and interventions to protect these communities from the impacts of these factors.